Primary and Secondary Effects of Mass Antibiotic Distributions for Trachoma

Abstract I have two objectives in seeking a K23 career development award: 1. to improve our understanding of the effects of mass antibiotic distributions for trachoma by conducting an in depth analysis of populations in which trachoma has ostensibly been eliminated and by assessing the positive secondary effects of mass antibiotic treatments on childhood morbidity and mortality; 2. to develop my career as an independent investigator through didactics, mentorship and hands-on research experience in the developing world. I will benefit from the infrastructure of two clinical trials: TANA (Trachoma Amelioration in Northern Amhara, U10 EY016214) and PRET (Partnership for the Rapid Elimination of Trachoma, Gates Foundation, #48027). The WHO launched the GET 2020 (Global Elimination of Trachoma by the year 2020) program to eliminate blinding trachoma, however, the goals have not been met, particularly in hyperendemic communities. Mass treatments have been used in several elimination campaigns and have been found to have unintended secondary effects. I have the following specific aims: SA1: To determine if C. trachomatis infection can be eliminated using rRNA-based nucleic acid amplification compared to DNA-based testing. SA2a: To determine if azithromycin treatments reduce mortality in 1-5 year olds from diarrhea, respiratory disease and malaria. SA2b: To determine if azithromycin treatments effect increases in height, weight, and arm circumference. My goal is to determine if complete elimination is attainable in hyperendemic communities and then to translate these research findings quickly into practice within trachoma programs in general and within the WHO GET 2020 program in particular. Growth indices are a common method for determining the efficacy of mass treatment; developing and testing an instrument for measuring growth and nutrition will provide an important bridge to future studies on integration of trachoma with other neglected tropical diseases (NTD).

Public health relevance
Public Health Relevance: The goal of this project is to improve our understanding of mass antibiotic distributions for trachoma, assessing populations in which trachoma was presumably eliminated, and evaluating for secondary effects of these mass treatments. This is critical for establishing both the efficacy and safety of the WHO Global Elimination of Trachoma campaign. __SpecificAimsTextDelimiter__ 10. Rationale and Specific Aims Primary and Secondary Effects of Mass Antibiotic Distributions for Trachoma The goal of this project is to advance our understanding of mass antibiotic distributions for trachoma by rigorously evaluating populations in which chlamydia was presumably eliminated, and assessing for secondary effects of these mass treatments. This study will use populations from three trials: TANA (Trachoma Amelioration in Northern Amhara, NEI U10), PRET (Partnership for the Rapid Elimination of Trachoma, Gates Foundation) and TMMS (That Man May See, UCSF). Trachoma, caused by an infection with Chlamydia trachomatis, remains the most common cause of infectious blindness, and affects over 80 million people including 1 million who are blind. Mass antibiotic treatments with oral azithromycin are effective: the WHO global elimination campaign advocates mass treatments and over 20 million doses of oral azithromycin have been distributed. However, much remains unknown, including: what the frequency and total number of treatments should be; whether complete elimination is possible; if elimination is not possible, why; and what are the secondary effects of mass antibiotic treatments. Previous and ongoing work demonstrates that mass distributions of azithromycin can reduce C. trachomatis infection to undetectable levels. However, infection often returns; possibly from reintroduction or possibly from persistent infection not detected because the current chlamydia assay lacks sensitivity. Our prior studies sampled portions of communities and tested for infection with DNA-based PCR tests. To establish whether undetected infection is present after treatment, all individuals of a community, as opposed to a sample, could be assessed for infection. In addition, the newer, more sensitive, rRNA-based amplification assay could be used. Three trials in Ethiopia provide an ideal opportunity to rigorously evaluate for C. trachomatis in recently treated populations deemed infection-free by standard DNA-based PCR testing. Mass distributions of medicines for diseases of the eye have a long history, including Credé prophylaxis for ophthalmia neonatorum, vitamin A for xerophthalmia and ivermectin for onchocerciasis. Vitamin A distributions went beyond the ophthalmologic and produced reductions in mortality. And it is reasonable to expect positive secondary effects from azithromycin, a long-acting, broad-spectrum antibiotic. Preliminary data suggests mortality reductions in children following azithromycin treatments; but, it is unclear which specific diseases contribute to this overall reduction. Periodic distributions of azithromycin could also improve childhood nutritional status and growth indices, perhaps by treating gastrointestinal or other diseases that affect nutrient absorption and metabolism. Assessments of cause-specific mortality and growth parameters in azithromycin- treated children could identify these positive secondary effects. By designing and implementing achievable offshoot studies of larger studies, I will gain training and experience in community-based clinical trials, while addressing key research questions: Is complete elimination of ocular strains of chlamydia possible in severely affected communities? Do mass distributions of azithromycin affect specific causes of childhood mortality and childhood growth? The training and experience obtained while accomplishing my specific aims will allow me to embark on an independent research career involving clinical trials and international ophthalmology. Specific Aim 1: To evaluate for C. trachomatis infection in communities recently treated and deemed free of infection by standard DNA-based testing. Hypothesis 1: rRNA-based testing of all members of selected communities will identify previously-undetected C. trachomatis infection. Specific Aim 2: To identify secondary effects of mass azithromycin treatments by identifying causes of child mortality and evaluating growth indices in communities randomized to receive mass treatment with azithromycin compared to communities randomized to receive topical treatment. Hypothesis 2a: In children aged 1-5 years, azithromycin treatments will reduce mortality from diarrhea, respiratory disease and malaria. Hypothesis 2b: Children aged 1-5 years who receive azithromycin treatments will have greater increases in height, weight and arm circumference.